Role Of Innate Immunity to NeuroHIV in the cART Era

PROJECT SUMMARY
A significant percentage of people living with HIV/AIDS (PLWHA) exhibit HIV associated neurocognitive
disorders (HAND). With the development and improvement of combination antiretroviral therapies (cART) there
was a substantial decrease of the death and morbidity rates of PLWHA. Despite the cART progress, PLWHA
still present a high prevalence as chronic neuroinflammation, where the cellular mechanism(s) that drive such
inflammation have not been entirely defined.
Certain models of neuroinflammation define inter-cellular cytokine signalling as a major player in
neuroinflammation. These models propose that activation of microglia results in the production of inflammatory
cytokines and metabolites (e.g. IL-1α, TNFα, IL-6, C1q) that are recognized by astrocytes, leading to a
modification from non-reactive astrocytes to a range of pro-inflammatory or repair phenotypes. In this proposal
we aim to identify the molecular mechanisms that trigger the activation of intracellular innate immunity in
microglia, as well to characterize the cellular crosstalk between HIV infected and non-infected cells in the brain
under physiological concentrations of cART.
Our preliminary data from gene expression and viral interaction with innate sensing immune complexes points
to an activation of the cyclic GMP-AMP synthase (cGAS)/stimulator of interferon genes (STING) pathway in
microglia under cART. Thus, we hypothesize that the activation of the cGAS/STING pathway leads to episodes
of chronic neuroinflamation in the context of HIV and cART therapy . We will determine the impact of cART on
HIV cytoplasmic trafficking and the activation of innate immune sensing. We will characterize the biologic
consequences to HIV-mediated innate sensing in astrocytes and neurons under brain physiologic cART
concentrations. We will carry out an experimental plan to characterize the impact of activation of the
cGAS/STING in the brain with funcional assays, cyclic multiplex immunofluorescence and super-resolution
fluorescence imaging, machine learning analysis, single cell and bulk RNAseq, and multiplexed cytokine profiling
in iPSC-derived microglia and cerebral brain organoids.
These studies will define the activation of HIV mediated innate immunity in cells from the brain that are known
to be infected by HIV and the impact of this activation in the disruption of normal brain homeostasis by
inflammatory processes. At the heart of this proposal is the clarification and identification of the
mechanism(s) that drive and/or contribute to persistent neuroinflammation under cART that culminate
in HAND. Knowledge gained from this research plan can inform therapeutic potential to ameliorate
and/or reduce HAND in PLWHA.

Public health relevance
PROJECT NARRATIVE A high percentage of people living with HIV/AIDS develop HIV associated neurocognitive disorders despite effective systemic antiretroviral therapy. The circumstances leading to persistent neuroinflammation, which play a part in neurocognitive disorders, are currently not defined. We will characterize mechanisms of HIV detection in the brain that can trigger neuroinflammation, this knowledge can inform future therapies.